Immunology of advancing disease among minorities with Multiple Sclerosis

PROJECT SUMMARY
Greater disease severity and a more rapid disease progression is observed among US minority populations
such as African Americans (AA) and Hispanics (Latinx) with Multiple Sclerosis (MS) compared to whites with
MS. Despite these observations, very little data is available regarding the biological underpinnings resulting in
this increased risk of unequivocal advancing disease among minorities with MS even though the incidence of
MS disease is growing among minority populations. Further, there are concerns that AA and Latinx with MS
are refractory to first-line therapies, which increases the concern that the poor outcomes reported reflect
substandard care and treatment.
Our long term goal is to facilitate prevention of neurological deficits in minority patients with MS by identifying
the mechanism(s) of CNS inflammation contributing to intensified progression and severity of disease. Others
have shown that minorities with MS display higher IgG index and synthesis rate, oligoclonal band positivity and
an inverse correlation of IgG index with gray matter atrophy. These data support a pronounced role for B cells
and their antibody products in the pathobiology of MS in minority populations.
Our central hypothesis is that the underlying mechanism of unequivocal advancing disease among minorities
with MS involves expansion of plasmablasts producing antibodies and/or inflammatory products that cause
neuronal toxicity independent of genetic (i.e. ancestral) predispositions. These studies will provide novel
mechanistic insights into the role of neuron-reactive plasmablasts in CNS inflammatory events associated with
intensified progression and severity of disease in minorities with MS. Our findings will also support future
studies to develop diagnostic and predictive tools that inform patient response to treatment and inform clinical
course such as relapse of MS or progression to MS in minority populations.

Public health relevance
NARRATIVE Minorities with MS face increased disease severity in comparison to whites with MS, possibly due to the differences in the immune responses between the populations, making it important to understand the contribution of the immune response to disease severity in Minorities with MS. We have observed that plasmablasts are expanded in Minorities with MS in comparison to whites with MS. In this project, we will test whether these expanded plasmablasts make antibody that binds to neurons and makes disease worse using a mouse model.